PLACEBO CONTROLLED TRIAL OF LITHIUM FOR INSOMNIA IN FREE-RUNNING BLIND PEOPLE

This study evaluates the effect of lithium in synchronizing the sleep-wake cycle in totally blind subjects. The effect of lithium treatment (1 month) is monitored by evaluating the circadian rhythm of melatonin production during sleep.